Bioinformatics

The principal objective of the Bioinformatics Core will be to provide project investigators a resource for bioinformatics analysis and interpretation of high throughput experiments performed in each project. In support of this objective, the specific aims of the Bioinformatics Core B include: 1. Analysis of ChlP-seq results 2. Analysis of microarray or RNA-seq measures of mRNA and miRNA abundance 3. Identify biological networks that operate among different cell types in the tumor microenvironment 4. Develop decision-making tools for TME biomarkers and human relevance

Public health relevance
RELEVANCE (See instructions): Bioinformatics Core B will provide analysis of high throughput experiments performed in Projects 1, 2, and 3. This resource will identify biochemical and genetic networks that are important in the interactions of cell types in the tumor microenvironment.